Modeling intra- and inter-cellular networks for TRPC6-dependent cardiac fibrosis

Summary
Heart disease remains the leading cause of death worldwide with a major contributor being coronary artery
blockage and myocardial infarction (MI, affecting ~800K/year in US). As a result, a substantial fraction of cardiac
muscle is permanently replaced with fibrotic scar. Fibrosis affects not just the heart but all organs, with no
available efficacious antifibrotic therapies due to the field's limited understanding. Most experimental studies
have pursued reductionist approaches to identify individual targets against fibrosis, such as the promising target
TRPC6. Yet as with other targets, how TRPC6 mechanistically drives myofibroblast transition remains poorly
characterized, limiting clinical translation. Here, we seek to define the multi-scale intra- and inter-cellular
signaling networks mediating TRPC6-dependent cardiac fibrosis. This leverages our preliminary data
characterizing the TRPC6 interactome, as well as our new computational methods and models that map
pathways from novel protein interactions into the fibroblast intracellular-intercellular signaling network. To meet
this challenge, we introduce a new computational method, Logic-Based Network Expansion with Protein
Interactomes (LogNEPRI). LogNEPRI maps pathways from novel interactions to a validated network model,
which bolsters subsequent experimental validation. By integrating multi-scale computational models and
experiments ranging from genetic and proteomic screens to mice, we test the overall hypothesis that the TRPC6-
interactome induces myofibroblast transformation and fibrosis in response to both cardiac and dermal wounds.
In Specific Aim 1, we develop LogNEPRI to integrate multi-omic data (overexpression screens, proteomic screen
for TRPC6 partners) to automatically expand a mechanistic network model to predict and experimentally validate
TRPC6-dependent drivers of myofibroblast transformation. In Specific Aim 2, we integrate the LogNEPRI-
expanded model of intracellular fibroblast signaling with a model of intercellular inflammation-fibrosis signaling
post-myocardial infarction, which we validate by global knockout and fibroblast-specific overexpression of
TRPC6/ARHGEF2 in vivo. The generality of predicted roles for TRPC6/ARHGEF2 will be further validated in
dermal fibroblasts and dermal wounds. Overall, these studies will establish a new computational approach
LogNEPRI for automated expansion of network models that integrates multi-omic data with highly-validated
network models. This approach and a new multi-scale computational model of intra-intercellular signaling of
fibrosis will identify and validate novel pathways that explain how a high-priority target (TRPC6) modulates
fibrosis after myocardial infarction and dermal wounds.

Public health relevance
Narrative Heart disease remains the leading cause of death worldwide with a major contributor being coronary artery blockage and myocardial infarction. Here, we combine a new computational method for integrating omic data into network models, a multi-scale model coupling intra-intercellular signaling, and new targeted genetic perturbations in cells and mice to identify how TRPC6 drives fibrosis in the heart and skin.